SBIR, Innovative Immersive Technologies for Evidence-Based Violence Prevention among College Students

ABSTRACT
Innovative Immersive Technologies for Evidence-Based Violence Prevention among College Students
This Phase II proposal will develop and test innovative virtual reality (VR) modules for an evidence-based primary
prevention approach to violence among college age youth. The proposed VR modules will be designed to
supplement an existing evidence-based violence prevention intervention approach developed as part of two
previous federally funded research and development projects; one for incoming college students funded by a
NIH/NIDA SBIR Fast-Track, and a second for incoming Air Force cadets funded by the U.S. Air Force. These
violence prevention projects for college-age youth were adaptations of a successful evidence-based substance
abuse and violence prevention approach initially designed for middle school youth called Life Skills Training
(LST). The LST approach builds personal self-management skills, social skills, and other life skills needed to
reduce substance abuse and violence, increase resilience, and successfully navigate developmental tasks. The
LST program has been extensively tested and found to effectively prevent substance abuse, violence and
aggression, and sexual violence in a series of randomized controlled trials (RCTs) involving 18 separate cohorts
of students from different populations and age groups, with behavioral effects reported in over 35 peer-reviewed
publications. An adaptation of LST for college age students was recently tested in an RCT at the U.S. Air Force
Academy and was found to reduced sexual acts without consent by nearly half (4.4% versus 7.4%) among first-
year cadets, representing one of the first rigorous studies at a U.S. Service Academy to demonstrate reductions
in sexual violence. To build upon this successful adaptation for college violence prevention, in Phase I, we
developed prototype VR modules designed to provide learning experiences through interactive and engaging
behavioral rehearsals and branched scenarios that allow for deeply immersive skills practice in conflict resolution
and bystander intervention strategies and in identifying health and unhealthy relationships and interactions. We
tested the prototype materials with 65 first year college students and university educators/administrators to
demonstrate feasibility, relevance, usability, appeal, and proof-of-concept. All benchmarks for moving to Phase
II were successfully surpassed. In Phase II, based on feedback from Phase I, we will fully develop a set of VR
modules that will include dynamic scenarios to [practice cognitive, social, self-regulation, emotional
perspective-taking, and healthy relationship skills to build resilience associated with reduced college
violence as well as reduced alcohol/drug abuse; positively change social norms, and train bystanders
to identify and appropriately respond to problematic situations.] The proposed product has the potential to
fill a gap in the preventive intervention tools currently available to colleges, and can be widely disseminated
throughout the country using existing marketing and dissemination channels to four-year colleges, community
or junior colleges, universities, graduate and professional schools, trade, and career and technical schools.

Public health relevance
NARRATIVE Innovative Immersive Technologies for Evidence-Based Violence Prevention among College Students This Phase II proposal will develop and test innovative and engaging virtual reality modules to prevent multiple forms of violence among college students, including youth violence, dating violence, and sexual violence. The proposed VR modules will be designed to provide immersive learning experiences through interactive and engaging behavioral rehearsals and branched scenarios to address risk and protective factors and build skills that prevent violence, based on the Life Skills Training (LST) prevention model. The violence prevention materials hold significant promise for wide dissemination to prevent violence among college-age youth at four-year colleges, community or junior colleges, universities, graduate and professional schools, for- profit schools, trade schools, and career and technical schools.